A PTP4A3 inhibitor for SARS-CoV-2-mediated acute lung injury

The Severe Acute Respiratory Syndrome coronavirus (SARS-CoV-2) is responsible for the current
COVID-19 pandemic. SAR-CoV-2, like other coronaviruses, infects human airways and enters cells via its S
(Spike) protein, which binds to the human angiotensin-converting enzyme 2 (ACE2) and is primed by the host
serine protease TMPRSS2. Both ACE2 and TMPRSS2 have been observed on pulmonary microvascular
epithelium and endothelium. A subset of COVID-19 patients develop acute respiratory distress syndrome
(ARDS) and subsequently septic shock and multi-organ failure; about half will die. The clinical worsening in the
later phases of COVID-19 are thought to result from Spike protein binding to the pulmonary microvascular
endothelium and epithelium, which leads to a damaged respiratory tract and ultimately a systemic inflammatory
response or cytokine storm. There are currently no FDA-approved drugs/therapeutics that treat the pulmonary
damage and ARDS associated with COVID-19. KeViRx is proposing to develop an entirely new therapeutic
strategy that prevents or mitigates the initial pulmonary damage and halts the lethal cytokine storm.
Our lead compound, KVX-053, is a reversible, selective, allosteric inhibitor of PTP4A3 phosphatase with
excellent in vivo pharmacokinetic properties and drug-like properties. Moreover, mice tolerated multiple
exposures to KVX-053. In culture KVX-053 was not cytotoxic to human ovarian epithelial cells or fibroblasts at
concentrations up to 25 µM. Surprisingly, we found that KVX-053 markedly enhanced the pulmonary
microvascular barrier function before and after injury caused by bacterial lipopolysaccharide and vascular
endothelial growth factor. PTP4A3 phosphatase is known to be induced in lung cells 12 h after SARS-CoV
infection and to control cytokine release. The overall hypothesis of this Phase I SBIR application is that the
PTP4A phosphatase family has a sentinel role in the acute lung injury of ARDS and the systemic inflammatory
response in COVID-19.The overall goal of the project is to repurpose KVX-053 for use against SARS-CoV-2
infection and for future viral pandemics involving acute lung injury. This Phase I SBIR application has three proof-
of-concept Specific Tasks. Specific Task 1 will determine the ability of a novel, potent, allosteric, small molecule
PTP4A inhibitor, KVX-053, to block SARS-CoV-2 Spike 1 protein-mediated loss of pulmonary endothelial barrier
function and cytokine release in vitro. Specific Task 2 will determine the ability of KVX-053 to block SARS-CoV-
2 Spike 1 protein-mediated pulmonary alveolar epithelial barrier function and cytokine release in vitro. Specific
Task 3 will determine the ability of KVX-053 to inhibit acute lung injury in mice caused by the SARS-CoV-2 Spike
1 protein.

Public health relevance
The overall goal of this Phase I SBIR application it to evaluate the usefulness of KVX-053, an experimental small molecule that targets the PTP4A3 phosphatase, as a therapy for the acute lung injury (ALI) observed in Acute Respiratory Distress Syndrome and the systemic inflammatory response associated with COVID19. Our ultimate goal is to repurpose KVX-053 for use in individuals with COVID-19 and for future pandemics involving ALI.